Protein homeostasis in hematopoietic stem cells

ABSTRACT
Hematopoietic stem cells (HSCs) regenerate blood and immune cells throughout life. Unfortunately, HSC
function declines with age. Age-related defects in HSCs lead to anemia, impaired immunity, bone marrow failure
and cancer. Thus, understanding mechanisms that contribute to HSC aging is critical for developing strategies
to enhance regeneration and tissue function in older adults. Protein homeostasis (proteostasis) dysfunction
contributes to several age-associated pathologies, but diminished proteostasis has not been examined as a
mechanism of HSC aging. We recently discovered that HSCs are particularly dependent on proteostasis to
preserve their self-renewal capacity. However, misfolded proteins arise in HSCs and therefore must be
eliminated to preserve HSC fitness. Canonically, the proteasome serves as the primary pathway for degradation
of misfolded proteins, but we found that proteasome activity is low within HSCs. This raises a fundamental
paradox: if HSCs are highly dependent on proteostasis, why do they have such limited proteasome capacity to
degrade misfolded proteins? In preliminary studies, we found that mouse and human HSCs preferentially
express the co-chaperone Bag3, which can promote delivery of misfolded proteins to aggresomes. Aggresomes
are inclusion bodies containing misfolded and aggregated proteins that typically form in response to stress and
are substrates for a selective form of autophagy (aggrephagy). We determined that HSCs form aggresomes,
even under steady state conditions, and they depend on autophagy to degrade protein aggregates in vivo.
Furthermore, we generated data demonstrating that protein aggregates accumulate in aging HSCs and that old
adult HSCs activate Hsf1, key proteostasis sensor that helps preserve HSC fitness. Based on these data, our
central hypothesis is that HSCs preferentially shuttle misfolded proteins to aggresomes and depend on
aggrephagy to maintain proteostasis, fitness and longevity. Furthermore, we propose that accumulation of
aggregated proteins contributes to age-related declines in HSC function. In Aim 1, we will test if mouse and
human HSCs preferentially form aggresomes. Using conditional Bag3 knockout mice, we will test if disrupting
transport of misfolded proteins to aggresomes impairs HSC function, proteostasis and aging. In Aim 2, we will
use genetic mouse models to express disease-associated protein aggregates in HSCs to test the effects of
protein aggregation on HSC function. We will also determine if aggrephagy regulates HSC fitness, protein
synthesis and quiescence. In Aim 3, we will quantify protein aggregates in aging mouse and human HSCs, and
test if protein aggregation induces Hsf1 activation. Finally, we will test if enhancing Hsf1 activity rescues age-
related declines in HSC function. Research outcomes will uncover how misfolded proteins are eliminated in
HSCs and if accumulation of aggregated proteins contributes to HSC aging. These studies will identify strategies
to manipulate proteostasis to enhance HSC fitness and delay/prevent hematological disease in older adults.

Public health relevance
PROJECT NARRATIVE Blood-forming stem cells in the bone marrow regenerate blood and immune cells throughout life. Defects in stem cell maintenance that occur during aging lead to anemia, impaired immunity and leukemia, but the underlying cause of these defects is largely unknown. This proposal will examine if blood-forming stem cell maintenance and fitness is disrupted by the accumulation of aggregated protein, and will identify unique pathways used by stem cells to limit protein aggregation and enhance longevity.